Administrative Supplement for Research on Vitamin B3 Dietary Supplements for Eye Disease

Abstract: Vitamin B3 (nicotinamide) is a widely available dietary supplement that is often
marketed as an anti-aging agent. Scientific studies of vitamin B3 have largely centered on its
role as a precursor to nicotinamide adenine dinucleotide (NAD+), a coenzyme and co-substrate
that is key to cellular metabolism. Reductions in NAD+ levels are thought to be linked to reduced
mitochondrial efficiency and to promote numerous diseases. Conversely, strategies which
increase cellular NAD+ levels―such as vitamin B3 dietary supplementation―might promote
health and prevent disease. Our currently proposed studies derive from scientific work that has
begun to test this framework for the blinding eye disease, glaucoma. Glaucoma is a group of
age-related neurodegenerative diseases characterized by loss of retinal ganglion cells (RGCs)
and their axons that is often precipitated by elevated intraocular pressure (IOP). Because RGCs
are post-mitotic neurons, their loss is permanent and causes a gradual decline leading toward
irreversible blindness. A 2017 paper in the journal Science suggested that an age-related
decline of NAD+ in the retina might render RGCs susceptible to glaucoma and that dietary
supplementation of vitamin B3 lessened disease severity in one widely used mouse model of
glaucoma (the DBA/2J model). Follow-up studies have begun to test additional agents which
modulate NAD+, such as nicotinamide riboside; to examine mouse models with other forms of
ocular disease; and some clinical trials have advanced to phase 2. Despite these advances,
there are many unanswered questions regarding the significance, model specificity, and
mechanisms of these findings. In 2019 our Glaucoma Center initiated a replication study of
DBA/2J mice treated with nicotinamide and began a parallel study with the nee mouse model of
severe congenital glaucoma. Unfortunately, challenges related to the COVID-19 pandemic
prevented us from completing these experiments. This administrative supplement for
R01EY030366 “Novel Genome Editing for the Treatment of Glaucoma”, will allow us to
complete the quantitative assessment of the optic nerves from these mice. We will also examine
how dietary vitamin B3 alters IOP―an important but under studied question. Specifically, we will
test whether there is an interaction between ATF4 activated pathways and nicotinamide. This
supplement will enhance our parent award and move us toward improved glaucoma therapies
by completing an important replication study with DBA/2J mice using quantitative assessments
of axon number, completing a test of neuroprotection in nee mice with severe glaucoma, and
testing a mechanism relevant to both ATF4 and nicotinamide in influencing IOP.

Public health relevance
Project Narrative: Glaucoma is a common group of age-related neurodegenerative diseases characterized by loss of retinal ganglion cells and their axons that carry information from the eye to the brain. Vitamin B3 (nicotinamide) is a widely available dietary supplement that has been proposed to have protective effects on glaucoma. The work of this Administrative Supplement will use new tools for quantitative phenotyping of the optic nerve to attempt replicating and extending experiments testing the influence of dietary nicotinamide supplementation on mouse models of glaucoma.